PBK: A novel mediator of VSMC proliferation and vascular remodeling in PAH

PROJECT SUMMARY
Pulmonary Arterial Hypertension (PAH) is a debilitating and eventually lethal disease that is resistant to
current therapeutics. A defining characteristic of PAH is excessive cellular proliferation and remodeling of
pulmonary arteries (PA), that results in progressive increases in pulmonary vascular resistance leading to right
ventricular failure and death. PAH has a survival time of five to seven years post diagnosis, and most of the
current therapies for PAH are vasodilators, which provide symptomatic relief, but do not reverse pulmonary
vascular remodeling or stop disease progression. We have discovered a novel gene, PDZ-Binding Kinase (PBK)
that is upregulated in hypertensive PA. PBK is a serine/threonine kinase that is overexpressed in a subset of
aggressive cancers. The hyperproliferative nature of vascular cells in PAH shares many mechanisms with that
of cancer cells, however, the therapeutic utility of targeting PBK in PAH and the mechanisms by which PBK
influences pulmonary vascular remodeling are not yet known and are the goals of this proposal.
In preliminary experiments in experimental models and human PAH, we show that PBK is robustly
upregulated in the medial layer of PA where it overlaps with markers of smooth muscle cells. Gain and loss of
function approaches show that PBK expression regulates pulmonary artery smooth muscle cell (PASMC)
proliferation. In experimental rat and mouse models of PAH in vivo, we found that selective inhibitors of PBK
improve PA remodeling and cardiopulmonary function. To determine the mechanisms underlying increased
expression of PBK, we found that the transcriptional co-activator, Yes Associated Protein1 (YAP1) was
upregulated in PAH and increased PBK promoter activity and PBK protein expression in PASMC. We employed
a proximity ligation approach to identify novel substrates of PBK which revealed Protein Regulator of Cytokinesis
1 (PRC1) as a binding partner. PBK upregulated PRC1 and induced PRC1 phosphorylation and cytokinesis in
PASMC. These novel preliminary data inform our central hypothesis that YAP1 upregulates PBK in PASMC to
enhance proliferation via PRC1 mediated cytokinesis. Collectively these mechanisms contribute to pathologic
pulmonary vascular remodeling and PAH. This hypothesis will be tested using integrated molecular, cellular,
genetic, imaging, and translational pharmacological approaches in multiple rodent models including a PBK KO
rat. Our long-term goal is to define the key mechanisms by which PBK regulates PASMC proliferation to
orchestrate changes in arterial remodeling, a hallmark of PAH. At their conclusion, the proposed studies will
move the field forward by defining novel signaling pathways in PAH and a novel mechanism of PASMC
proliferation. These studies will also advance the utility of novel therapeutic approaches targeting PBK and
cytokinesis to reduce PA remodeling and subsequently improve the morbidity and mortality associated with PAH.

Public health relevance
PROJECT NARRATIVE Pulmonary arterial hypertension (PAH) is a disease that is caused by structural changes in pulmonary arteries (PA) that promote high pulmonary arterial blood pressure and ultimately right heart failure and eventual death. In pulmonary tissue from experimental and human PAH we have discovered the upregulation of a novel gene, PDZ-Binding Kinase (PBK) that promotes smooth muscle cell proliferation. Specific pharmacological inhibitors of PBK reduce PAH in animal models and the goal of our studies is to define a role for PBK in the eitiology of PAH and establish the utility of PBK inhibitors as a therapeutic strategy to improve the morbidity and mortality of a disease for which there are few effective therapeutic options.